Environmental Toxicology and Epidemiology Pre- and Post-Doctoral Research T32 Training Program

ABSTRACT
The objective of the Environmental Toxicology and Epidemiology (ETEP) training program is to train future
leaders in the environmental health sciences by providing research training that bridges environmental
toxicology (basic research) and epidemiology (population-based research) with applications to human disease
prevention. The program is based on the premise that environmental health scientists who specialize in
toxicology or epidemiology require training in multiple disciplinary approaches to conduct impactful translational
research, encompassing the rapidly evolving approaches used in genomics, proteomics, bioinformatics and
data science. The proposed program represents evolutionary changes to our highly successful program, now
in its 40th year. In this submission, we request 6 predoctoral and 3 postdoctoral positions (at levels 0, 1 and 2).
Predoctoral trainees specialize in environmental epidemiology or toxicology, and complete foundation and
advanced courses in the non-specialization area (e.g., epidemiology trainees complete toxicology courses and
vice versa), and all trainees complete a common core curriculum that includes courses in bioinformatics or
data science and the responsible conduct of research. Predoctoral trainees must have a baccalaureate
degree with relevant scientific coursework preparation and will be enrolled in a PhD program in the
Environmental Health Sciences Department, which has a distinguished history of graduate training in
toxicology and environmental health sciences. The expected duration of trainee support from the ETEP
training grant is two years; the expected duration of predoctoral training is 4-5 years. Postdoctoral trainees will
work with our ETEP faculty, complete research training and career development modules, and will be
encouraged to submit an individual NRSA Postdoctoral Fellowship application in their first year of training.
Qualified postdoctoral applicants must demonstrate motivation for careers in the environmental health sciences
addressing toxicology or epidemiology research, and have a PhD, MD, DVM or other appropriate doctoral
degree. The program is implemented and evaluated with the assistance of an Executive Committee, External
Advisory Committee, and a diverse pool of outstanding faculty mentors drawn from across the University of
Michigan.

Public health relevance
Project Narrative This Environmental Toxicology and Epidemiology Program trains future leaders in the environmental health sciences (EHS) who accelerate discoveries of how environmental exposures affect human health and promote improvements in public health. The program focuses on translational applications to human disease prevention with training that bridges environmental toxicology (basic research) and epidemiology (population-based research).